Assessing a Novel Paradigm of Inducing Cryotolerance

DESCRIPTION (provided by applicant):The practical goals of this study will be the development and optimization of a serum free cryoprotection medium with minimum levels of cryoprotectants. We intend to pursue these studies using a hypothesis-driven, mechanism-based experimental approach, i.e., the viability of the cryopreserved adult stem cells (ASCs), in the undifferentiated, adipocyte- or osteoblast- differentiated states, can be improved by increasing the pre-freeze expression of heat shock proteins (HSPs).

Public health relevance
This proposal will determine the link between the expression of heat shock proteins and pre-freeze (control) and post-freeze (cryopreservation) potential (osteogenic and adipogenic) of human adipose tissue derived adult stem cells (ASCs).